Virtual and Augmented Reality Interaction Core

Project Summary
Virtual and Augmented Reality Interaction Core
The Virtual and Augmented Reality Interaction (VARI) Core is designed to facilitate access and applications for
immersive visual stimulus environments. The core will continue to be directed and managed by Dr. Eelke
Folmer, Professor in the Department of Computer Science and Engineering, who specializes in augmented
and virtual reality research. Virtual reality and augmented reality are considered essential to the next
generation of visual and cognitive neuroscience research programs because of the novel and highly improved
opportunities to provide controlled immersive stimulus experiences that allow analysis of perception, cognition,
and behavior in naturalistic visual environments and tasks. The core was established in Phase II and
supported a wide array of projects within and beyond Center-supported faculty including a number of
extramurally funded projects. In Phase III we will continue to enhance and expand the equipment, training and
services required for neuroscience research using virtual reality and augmented reality resources. The core will
offer training and workshops in usage of this equipment, and software development services for developing
virtual reality and augmented reality applications. The technology and services through the core are essential
to efficiently support the growing cluster of visual and cognitive neuroscience faculty at UNR. In Phase III we
will further expand this user base including supporting the Pilot Project Program through the Center, and will
develop the policies and plans to progressively shift funding for the core from the COBRE to user-and grant-
based as well as institutional support.

Public health relevance
Project Narrative Virtual and Augmented Reality Interaction Core Virtual reality and augmented reality are considered essential to the next generation of visual, cognitive, and behavioral neuroscience research programs. This core will continue to provide the necessary hardware and software development services that will support a wide base of neuroscience and behavioral science faculty at the University of Nevada, Reno.